Stargardt/ABCA4 disease in African Americans

Project summary/Abstract
Disease-associated variation in the ABCA4 gene has emerged as the most prevalent cause of Mendelian
retinal disease affecting an estimated 50,000 people in the United States. The extensive clinical heterogeneity
of ABCA4-associated retinopathy, in short ABCA4-RD, which includes >40 clinical phenotypes entities (most
often called Stargardt disease (STGD1), cone-rod dystrophy (CRD), retinitis pigmentosa (RP)-like, etc.),
reflects its equally large genotypic profile with >2300 known disease-associated variants. While the clinical and
genetic spectrum of patients of European descent has been advanced significantly since the discovery of the
ABCA4 gene in 1997, the same is practically unknown for underserved minorities, especially for patients of
African American (AA) descent. Only two studies have been performed in small cohorts of AA patients;
therefore, the absolute majority remain uncharacterized. Therefore, it is clearly necessary to fill this serious
void by comprehensive, integrated clinical and genetic analysis of ABCA4-RD in AA patients. We will test the
central hypothesis that, as in our previous studies in European patients, a combination of advanced genetic
screening coupled with quantitative clinical data and functional analyses of ABCA4 alleles from both coding
and non-coding sequences from the entire ABCA4 locus is necessary to unequivocally determine the ABCA4-
RD structure in AA patients. This program represents a collaborative effort between five centers, with
demonstrated expertise in recruiting and comprehensive clinical characterization of patients, including cases of
AA descent, deciphering genetic causes of ABCA4-RD, and ABCA4 functional studies. The program is
organized into three Specific Aims. The first Aim is dedicated to patient recruitment and clinical analyses,
research in the second Aim identifies and analyzes all variants in the entire ABCA4 locus and exome, and
defines genotype-phenotype correlations, genetically defined disease subgroups and the entire structure of
ABCA4 variation in AA patients. The third Aim is dedicated to functional analyses of most frequent ABCA4
alleles in AA cases by testing for their effect in structural modeling, protein function in in vitro assays, mouse
models and iPS-derived retinal organoids. The proposed research will uncover and functionally verify the most
frequent ABCA4 disease-associated variants in AA patients, thereby substantially advancing precise disease
diagnosis, will refine clinical prognosis for ABCA4-RD caused by specific ABCA4 alleles, resulting in variable
age of disease onset, expression, and progression. Integrating clinical, genetic, and functional data in the
analyses and, eventually into a prediction matrix will improve diagnostic accuracy, prognostic counseling and
will provide a platform for designing precise phenotype-specific treatment in clinical trials for ABCA4-RD in
African Americans.

Public health relevance
Project Narrative Disease-associated variation in the ABCA4 gene is the most prevalent cause of Mendelian retinal disease with extensive clinical heterogeneity including >40 clinical phenotypes, which reflect its equally vast genotypic profile with >2300 known disease-associated variants, together comprising ABCA4-associated retinopathy, ABCA4-RD, which is well-characterized in European population, but almost practically unknown for underserved minorities, especially for patients of African American (AA) descent. The proposed research program, based on large, comprehensively characterized cohort of AA patients with ABCA4-RD from 5 urban centers, is using integrated approaches of genetic analyses, quantified clinical data and functional analyses to determine the pathogenic variation in the ABCA4 locus and in the genome thereby generating a prediction matrix for ABCA4-RD for AA patients. The outcome of these studies will substantially improve diagnostic accuracy, prognostic counseling and will provide a platform for designing precise phenotype-specific treatment in clinical trials for ABCA4-RD in AA population.